COMPARISON OF TWO DOSAGE REGIMENS OF ORAL DAPSONE FOR PROPHYLAXIS PCP

Comparison of two doses of dapsone as PCP prophylaxis in HIV infected infants and children who are intolerant to trimethoprim-sulfamethoxazole (TMP-SMX). The primary objectives are to compare the toxicity of daily vs. weekly dapsone in HIV-infected infants and children and to study the pharmacokinetics of orally administered dapsone in HIV-infected infants and children.